Retinal mechanisms of refractive development

ABSTRACT
Myopia is the leading cause of vision impairment worldwide and is predicted to affect half of the global
population by 2050. Although widely available, optical corrections such as glasses and contacts do not treat
the underlying causes of myopia, resulting in millions of people being at an increased risk of developing
blinding diseases later in life from retinal detachment and degeneration, glaucoma, and cataracts. Currently, it
is known that a combination of complex genetic and environmental factors contribute to myopia development.
For example, parental myopia increases the risk of myopia in children, and ambient light level exposure
strongly correlates with myopia susceptibility. However, the genetic landscape that influences myopia is highly
polygenetic and the mechanisms that drive changes in the retina, choroid, and sclera, which ultimately alter
refractive error, remain elusive. In this proposal, we aim to use mice with a genetic predisposition to myopia or
hyperopia to identify the genetic contributions to myopic eye growth, the influence of environmental factors on
myopia susceptibility, and the components of the retinoscleral signaling cascade modulating refractive
development. We outcrossed two inbred mouse strains, C57BL/6J and 129S1/SvlmJ, and generated second
generation (F2) mice with hyperopic and myopic refractive errors, respectively. Taking advantage of the highly
characterized mouse genome, we will use a genome-wide single nucleotide polymorphism (SNP) based
strategy to identify regions of the genome that are associated with refractive errors through qualitative trait loci
(QTL) mapping. Our preliminary analysis identified Dlgap2 as a promising candidate gene since it has been
reported in human myopia genome-wide association studies. In the proposed experiments, we will test two
QTL-identified candidate genes in targeted mouse mutants. We will also determine gene-environment
interactions by investigating the response of the F2 mice to lens defocus myopia and different ambient light
conditions. The genetic loci associated with the myopic phenotype in F2 mice will be compared to loci
associated with lens-induced myopia. Lastly, we will use the F2 mice to investigate if dopamine- and/or
hypoxia-associated signaling are necessary for myopic eye growth. Our proposed strategies will significantly
expand our understanding of the polygenetic networks underlying myopia, increase our knowledge of the
retinoscleral signaling needed for myopic eye growth and thus, form the basis for developing novel and more
effective treatments for myopia.

Public health relevance
NARRATIVE Myopia continues to increase at alarming rates due to complex genetic and environmental factors; however, the exact mechanisms remain elusive. We propose to use mice with a genetic predisposition to myopia or hyperopia to identify the genetic contributions to myopic eye growth, the influence of gene-environment interactions on myopia susceptibility, and the components of the retinoscleral signaling cascade modulating refractive development. These experiments are posed to reveal candidate genes and retinoscleral signaling components that are necessary for myopia eye growth, providing novel targets for treatments and interventions.